Genetics and Genomics of Human Disease

Project Summary/Abstract
Continuing support is requested for years 41-46 of the Yale Predoctoral Training Program in Human Genetics
and Genomics. The program constitutes 44 trainers, the majority of whom are primary or secondary appointees
in the Department of Genetics at the School of Medicine. Virtually all of the trainees over the last funding period
have been matriculated in the Molecular Cell Biology, Genetics & Development Track (MCGD) in Biological and
Biomedical Sciences at Yale. The proposed training program is focused on the use of genetic, genomic and
computational approaches to understand human biology and disease. Training encompasses three core
domains: 1) The genetics of human health and disease, encompassing disease gene discovery and the
interpretation of human genetic variation; 2) Computational approaches to obtain biological insights from
complex genomic datasets, both in human and model systems; and 3) Experimental studies in model organisms
to understand how human genetic variation influences human biology and disease. Training faculty include
investigators who are world leaders in each of these domains. This integrated training environment provides
trainees with broad exposure to genetics, genomics and computational biology, and a rich training environment
that prepares them for careers in science. Students admitted into the program have strong scientific backgrounds
and research experience with high academic achievement. First year students are supported by Yale. Students
are then supported by the training grant in years 2 and 3, and thereafter by funds in Training Faculty laboratories
until graduation. Training in the first year includes formal course work focused on genetics, genomics and data
analysis, as well as research rotations leading to selection of the thesis advisor and laboratory. In the second
year, students complete course work and take a qualifying exam in which they must demonstrate mastery of
genetics and defend two written research proposals. Subsequent years are devoted to dissertation research,
development of experimental and analytic skills, and skills in written and oral presentation, leading to preparation
and publication of the thesis work. In addition, students engage in supervised teaching experiences. The
students also participate in Program-specific activities, including a Program Retreat, a Program Symposium,
dedicated Research-in-Progress talks, and a Program Seminar Series. These activities provide students with
targeted mentoring and career development opportunities and will help them develop a professional network of
peers and senior colleagues that they can draw upon throughout their careers. Support is requested for 5 years
for 7 Ph.D. students per year. Trainees are highly successful in completing their Ph.D. thesis work, publishing
their work in high-impact journals, and the vast majority continue to contribute to science after leaving the
program.

Public health relevance
Project Narrative Rapid and inexpensive DNA sequencing technologies have revolutionized medicine by revealing the landscape of mutations that contribute to human disease. Over the next decade, whole genome sequencing of many thousands of individuals, coupled with novel genome editing approaches to determine the impact of specific human mutations in experimental model systems, will provide unprecedented insight into disease mechanisms and empower new strategies for prevention, diagnosis and treatment. This training program will train the next generation of scientists to be able to take full advantage of this sea change in human genetics and prepare them for productive careers in science that will lead to improved human health.